Investigation of the neuroimmune axis in retinal regeneration.

Project Summary/Abstract
Loss of vision has a devastating impact on an individual's quality of life. Most blinding diseases result from loss
of neurons in the retina. A promising strategy to treat sight-threatening diseases, is to harness the regenerative
potential of cells within the retina. Müller glia (MG), possess an extraordinary capacity in lower vertebrates to
regenerate retinal neurons. However, in mammalian retinas, including humans, MG are unable to replace
neurons lost to injury or disease. Recently, we have developed strategies to neurogenically reprogram MG in
adult mice by overexpressing the transcription factor Ascl1 in MG. Remarkably, the treatment of Ascl1
overexpression, combined with NMDA-induced retinal damage and histone deacetylase (HDAC) inhibition,
causes MG to regenerate functional neurons in the adult mammalian retina. While this is significant progress
towards realizing the therapeutic potential of MG, only a subset of MG successfully reprogram into neurogenic
progenitors while another subset of MG express genes associated with inflammatory processes. We
hypothesized that the inflammation that accompanies neuronal cell loss restricts the regenerative potential of
MG. Indeed, we recently found that ablation of microglia, the endogenous immune cell of the retina,
dramatically improved MG-mediated retinal regeneration. This finding implicates the neuroimmune system as a
key component of the regenerative response of the mammalian retina. However, little is known about the
neuroimmune interface in retinal repair strategies such as endogenous regeneration. This proposal outlines
studies to better understand the neuroimmune axis during MG-mediated retinal regeneration and to develop
immunomodulation strategies to improve the regenerative capacity of the mammalian retina. The data
generated in this proposal will be foundational to Dr. Todd's ultimate goal of becoming an independent
investigator. During the K99 portion, Dr. Todd will expand his technical and theoretical expertise in
neuroimmunology to accomplish his aims studying immune-glial interactions during retinal regeneration. New
collaborations will be established with investigators in neuroimmunology and further training activities will
prepare Dr. Todd to become a successful investigator in the field. The training portion of this proposal will take
place at the University of Washington, which offers exceptional access to both research equipment and faculty
expertise to assist in the accomplishment of the applicant's goals.

Public health relevance
Project Narrative Mammalian retinas lack an intrinsic regenerative capability, so loss of neurons cause permanent vision loss in humans with neurodegenerative diseases. Recently, progress has been made in engineering mammalian Müller glia to replace lost neurons, however, we have found that the inflammation that accompanies neuronal loss restricts regeneration. In this proposal, experiments are outlined to determine how the neuroimmune system impacts Müller glia-mediated regeneration, with the objective to identify novel strategies for improving the regenerative potential of the mammalian retina.